The effect of aging on sensory neurons in C. elegans using in vivo imaging

DESCRIPTION (provided by applicant): Aging, a degenerative process when viewed from the biological prospective, is often associated with a high probability of an age-related disease or disability, low physical and mental function capacity and low engagement with life. Revealing how the overall neuronal functionality and how specific neuronal properties alter with age is considered to be a major step towards understanding the molecular mechanisms of age-related diseases and disorders. The multivariate, environment-dependant character of aging, led to the adoption of animal models that can be easily genetically manipulated, have a short lifespan and can develop and age in a controllable lab environment. Over the last three decades, C. elegans, a tiny nematode with powerful genetics and a well-defined nervous system, has become a prominent model organism for studying the process of aging. We propose to combine calcium imaging with microfluidics to quantify the effect of aging to the functionality of major sensory neurons (ASH, AWC, AFD) of C. elegans in vivo. We hypothesize that the biophysical properties of the sensory neurons in C.elegans are altered with age. We also hypothesize that oxidative stress is one factor that results in the degradation in the neuronal performance and that anti-oxidative stress substances can minimize oxidative damage. By using calcium indicators, we will be able to probe the biophysical properties (neuronal sensitivity, time response and amplitude of depolarization) of these neurons when triggered with a certain stimulus. The microfluidics will provide the automation that is required for obtaining repeatable and accurate imaging data from a large number of worms. In order to validate our hypotheses, imaging data from various populations of worms (wild-type, mutants and antioxidants-treated worms) of different ages will be compared and statistically significant trends will be obtained. PUBLIC HEALTH RELEVANCE: Aging is associated with a high probability of age-related diseases (Parkinson's and Alzheimer's disease), low physical and mental functional capacity and low engagement with life. We propose to study the effect of aging on sensory neurons in the nematode C. elegans using in vivo calcium imaging and microfluidic technology. We believe that our studies will deepen our understanding of the aging process in more sophisticated nervous systems

Public health relevance
Aging is associated with a high probability of age-related diseases (Parkinson's and Alzheimer's disease), low physical and mental functional capacity and low engagement with life. We propose to study the effect of aging on sensory neurons in the nematode C. elegans using in vivo calcium imaging and microfluidic technology. We believe that our studies will deepen our understanding of the aging process in more sophisticated nervous systems